Development of Machine Learning Composite Measures for Graft Outcome Selection in Pediatric Liver Transplantation

ABSTRACT
Outcomes in pediatric liver transplantation (pLT) are not limited by the donated organ supply. Kids are dying
waiting for organs even when these deaths are completely preventable through proper organ selection. Instead of
dying, children can live a full and active lifetime with a properly selected liver graft for transplant. Critical to
achieving zero waitlist mortality and long-term transplant benefit is the capacity to intervene in a timely manner
with a suitable organ and graft type. Decisions to proceed with pLT are complicated, ultimately based on the
alignment of transplant team experience, clinical assessment, and organ availability. In an era of organ shortages,
the use of technical variant (TV) grafts, including split liver transplantation and living donor liver transplant, has
the potential to expand graft choice and enable timelier surgical intervention. Most transplant programs that have
prior experience with TV grafts have low patient mortality and excellent transplant outcomes. However, some
transplant programs that have limited prior experience with TV grafts have reported many poor outcomes for
patients receiving TV transplants. Despite improvements in overall outcomes, national registry data have
confirmed significant variation among transplant centers in waitlist mortality, TV graft use, and post-transplant
outcomes. Integrally linked to this variation is the intricacy of transplant decision making. Collectively, donor
and graft acceptance, prioritization of candidates, and allocation policies depict a complex scenario. More than
100 variables can be considered in a single donor-recipient ‘‘best matching’’ decision, with a risk of subjectivity
and mismatch because of human limitations that should not be underestimated. Recognizing these limitations,
artificial intelligence classifiers, including machine learning and deep learning, have been recognized for their
potential to support or confirm decision making within the field of transplantation. Still, overall data-driven
support for optimal graft selection and dissemination of graft decision support is lacking. Opportunities for, and
the impact of, discovery are high. This project will result in a composite decision support software tool that uses
machine learning to predict and model the best survival for the patient using pre-transplant mortality, post-
transplant outcomes, and prior center experience. The decision support tool can be established to supplement
current graft selection practices in pLT. We anticipate that modeling based on composite measures will
demonstrate equivalent outcomes in recipients of TV grafts. We will develop an algorithm for optimal pediatric
graft-type selection that will be commercialized for use through the Starzl Network for Excellence in Pediatric
Transplantation and after further multi-center validation it will be available for all pediatric transplant programs.
We will accomplish our objective through the following three aims. One, determine the optimal feature space for
predictive variables for patient and pLT graft survival. Two, develop survival prediction models, “PSELECT,” for
remaining on the waitlist or receiving various graft types. Three, demonstrate the simulated technical feasibility
to eliminate the waitlist mortality based on the PSELECT performance on previously held-out data.

Public health relevance
PROJECT NARRATIVE Kids are needlessly dying waiting for an organ transplant because donor organ selection is difficult, and this is not due to an organ shortage. Optimal organ selection and waitlist management strategies have not been fully developed or disseminated, contributing to observed variability in waitlist mortality which varies from 0-2 deaths per 100 waitlist years to >20 deaths per 100 waitlist years at individual centers. The proposed project solves this problem and ends waitlist mortality by development of novel machine learning algorithms and real- time clinical decision support software to determine the optimal transplant graft for each child based upon predicted survival.